Proj3:Role of cytochrome P450 (CYP)1A/1B1 enzymes in the potentiation of neonatal lung injury in newborn mice exposed prenatally to PHs,and increased risk of premature infants to chronic lung disease

Project Summary
Pregnant women, living in the vicinity of Superfund sites, who are exposed to polycyclic
aromatic hydrocarbons (PAHs) that emanate from these sites, are at a higher risk for preterm
delivery. Preterm neonates, often require supplemental oxygen (hyperoxia), and contributes to
the development of bronchopulmonary dysplasia (BPD), the most common and serious
pulmonary morbidity in preterm neonates. The mechanisms by which PAHs potentiate BPD in
infants are not well understood. The central hypothesis of the research proposed in thjus project
is that pregnant mice exposed to a mixture of PAHs, i.e. benzo[a]pyrene (BP), ,
benzo(b)fluoranthrene (BbF), and dibenz[a,h]anthracene (DBA)], which are which are present in
Superfund sites, at environmentally relevant concentrations, will differentially exacerbate lung
injury and alveolar simplification in neonatal mice following postnatal hyperoxia, and that this
effect will be altered in mice lacking the gene for Ah receptor (AHR), Cyp1a1 and 1b1
(Cyp1a1/1b1 double knockouts), or Cyp1a1, 1a2, and 1b1 (Cyp1a1/1a2/1b1 triple knockouts) by
mechanisms entailing a combination of genotoxic and epigenetic mechanisms. We will also test
the hypothesis that the premature infants exposed prenatally to PAHs or other chemicals have a
greater risk of developing BPD than those exposed to lesser or no PAHs, and that human
pulmonary cells or mice exposed to remediated PAHs will exhibit lesser toxicity than parent PAHs.
To test these hypotheses, we propose the following Specific Aims: 1. To test the hypothesis that
prenatal exposure of wild type (WT) (C57BL/6J) mice to the PAH BP or a mixture of PAHs (BP +
BbF + DBA + DBP + IDP) will result in exacerbation of lung injury and alveolar simplification
following postnatal hyperoxia, and this effect will be altered in mice lacking the gene for AHR,
Cyp1a1/1b1, or Cyp1a1/1a1/1b1. 2. To determine the mechanisms by which prenatal PAHs will
alter the susceptibility of neonatal mice to hyperoxia. 3. To test the hypothesis that mothers
exposed to PAHs (that are present in Superfund sites) or other environmental chemicals (based
on unbiased metabolomics or exposome data from project 2) are at a greater risk for preterm
delivery, and that these infants will show increased susceptibility to develop BPD than those with
lesser or no exposure. 4. To determine the toxicity of un-remediated and remediated PAHs from
soils from Superfund Sites (e.g., Patrick Bayou) in (i) human pulmonary cells (e.g., BEAS-2B or
A549 cells) in vitro and (ii) in vivo using wild type mice. Accomplishments of these aims could
lead to novel strategies for the prevention/treatment in premature infants of BPD, which is
probably potentiated by maternal PAHs that emanate from Superfund sites.

Public health relevance
Project Narrative Pregnant women, living in the vicinity of superfund sites, who may be exposed to polyclic aromatic hydrocarbons (PAHs) that emanate from these sites, are at a higher risk for preterm delivery. We hypothesize that prenatal PAH exposure will exacerbate the effects of postnatal supplemental oxygen in newborn mice. Accomplishments of the aims of this project should be beneficial to stakeholders such as EPA and ASTDR, as we will be able to extrapolate the doses we give in animals to humans who might be exposed to PAHs.